Interplay between limbic norepinephrine and dopamine circuits in reward and aversion

PROJECT SUMMARY/ABSTRACT
Norepinephrine (NE) and dopamine (DA), the two major catecholamines in the brain, play a key role in
various psychological, physiological and behavioral processes ranging from reward and aversion to learning
and motivation. As important mediators of homeostasis, the central catecholamines have been implicated in
many neuropsychiatric diseases including substance use disorders. Despite a greater prevalence of such
diseases today, many modern pharmacotherapies for treating catecholamine-related disorders are non-specific
and lack efficacy due, in part, to a limited knowledge of the pathophysiology underlying local catecholamine
circuits. Accumulating evidence suggests that NE neurons in the locus coeruleus (LC) and the nucleus of the
solitary tract (NST), the main sources of brain NE, projecting to the ventral tegmental area (VTA, the primary
source of mesolimbic DA), have been regarded as regulators of limbic DA functions. Thus, new insights into
how the NE systems interact with mesolimbic DA are essential to understand DA-associated positive and
negative affective states. However, whether LC/NST-NE inputs to the VTA (LC/NST-NEàVTA) modulate
limbic VTA-DA signaling and whether there are sex differences in these pathways is still not well understood
due in part to limitations of conventional techniques that lack sensitivity, selectivity, and the spatial and
temporal resolution necessary to the target NE neurons.
In Aim 1, we will map the anatomical and neurochemical distribution of LC-NE and NST-NE projections to
the VTA and their contribution to VTA-DA regulation in the ventral striatum (nucleus accumbens (NAc) and
olfactory tubercle (OT)) via NE receptors and transporters in the VTA of male and female rats. For this Aim, a
novel combination of local chemogenetic manipulations of targeting the NE neurons coupled with a high-
density neurochemical sensing microelectrode array will be used.
In Aim 2, we will determine the functional role of LC/NST-NE signaling in the VTA on VTA-DA
transmission within the ventral striatum of male and female rats in anxiety-like/aversion and reward (drug)
seeking behaviors by optogenetically modulating the NE neurons in methamphetamine self-administration
paradigms.
These studies will (i) reveal the neurobiological mechanisms underlying the critical role of the LC/NST-
NEàVTA-DA within NAc/OT circuits in limbic catecholamine systems and their crosstalk linked to various
essential brain functions including reward/aversion and drug seeking as well as its distinct sex differences, and
(ii) provide insight into how these catecholamine circuits may be implicated in neuropsychological and
substance use disorders and may lead to novel sex specific treatment strategies.

Public health relevance
PROJECT NARRATIVE Brain dopamine (DA) and norepinephrine (NE) play key roles in many psychological, physiological, and behavioral processes, yet not much is known regarding the interactions between these neurocircuits underlying biological mechanisms of brain functions and behaviors due to methodological limitations. This proposal will determine how the poorly understood brain NE systems contribute to and modulate DA-associated positive and negative affects using an integration of novel genetic manipulation and neurochemical sensing techniques. These studies will provide novel insights into the interactions between local limbic NE and DA circuits to maintain homeostasis and initiate appropriate behavioral responses (e.g. reward seeking and avoidance) for survival.